High-throughput and multiplex single-molecule quantification and sorting of single EV

Extracellular vesicles (EVs) have gained significant attention for their diagnostic and therapeutic
potential due to their unique protein and RNA cargo, which play key roles in cancers and other
diseases. However, despite extensive research and investment, the clinical translation of EV
biomarkers remains limited. A major challenge is that EVs from diseased tissues often have
molecular similarities to those from healthy cells, with only subtle differences in their cargo. The
specific packaging of molecular cargo in individual vesicles is believed to be crucial to their
function, making bulk analysis methods insufficient. Single EV-level analysis is essential.
Current approaches, relying on low-throughput, high-resolution imaging, are hindered by the
vast number of EVs in clinical samples like blood (~1010 EVs/mL). To overcome this, we
propose Agarose Bead-based Digital Single Molecule-Single EV Sorting (BDEVS), a high-
throughput microfluidic platform for ultra-sensitive profiling of individual EVs in plasma. Unlike
conventional methods, BDEVS provides single-molecule sensitivity and multiplexing (>5 targets)
without compromising throughput, analyzing millions of EVs per minute. The platform uses
rolling circle amplification (RCA) of cleaved EV surface proteins, which are amplified in
microscale agar droplets, followed by flow cytometry-based readout and sorting. This approach
addresses previous limitations such as steric hindrance, non-specific binding, and limited
protein quantification on EVs.

Public health relevance
Extracellular vesicles (EVs) have attracted enormous attention for their diagnostic and therapeutic potential, and their unique molecular cargo of proteins and RNAs have been found to play important functional roles in many cancers. A key challenge in their study is that EVs from diseased tissues may contain similar molecules, with only nuanced differences in their cargo, compared to EVs from other cells, yet the specific packaging of multiple proteins and RNA into each individual vesicle is believed to be key to their functionality. We develop a high throughput digital platform to profile protein expression of individual EVs among the large background of EVs present in biospecimens.